Ambient Air Pollution, Weather, and Placental Abruption (APWA)

ABSTRACT
Placental abruption results in hemorrhage, ischemia, and fetal hypoxia, placing a tremendous health burden on both the
mother and the newborn. Efforts to understand the etiology of this devastating obstetrical complication have been disap-
pointing. This project will delineate environmentally-associated pathways to abruption and determine the impact of pol-
lutant triggers that are implicated in acute versus chronic placental abruption. Given that one-fourth of all abruption cases
have an acute etiology and 15% of abruptions may recur in future pregnancies, the role of environmental triggers is a
critically important, yet unexplored, opportunity to understand the pathophysiology of this enigmatic obstetrical compli-
cation. The project will capitalize on high resolution exposure and health outcome data as it aims to develop a birth linkage
database that will include hospital discharges linked to both stillbirths and live births-infant deaths to resident women in
California, Florida, Massachusetts, Michigan, and South Carolina (estimated 16 million births, including 155,000 abruption
cases) between 2000–2016. For each pregnancy we will assign average daily ambient exposure to fine particulate matter
with an aerodynamic diameter ≤2.5 µm (PM2.5), its constituents (elemental carbon and organic carbon, sulfate, nitrate,
and ammonium), as well as gaseous pollutants (nitrogen dioxide and ozone), using spatiotemporally resolved models that
predict exposure for each residential location. We will also assign every residence with average daily temperature, humid-
ity, dew point, heat waves, and atmospheric air pressure. The project will focus on disentangling the relative contributions
of ambient air pollution and weather-related conditions on acute abruption through a bi-directional, time-stratified case-
crossover design, and those of abruptions with chronic underpinnings using a cohort design. We will apply distributed lag
linear and non-linear models to identify critical windows of exposure, Bayesian Kernel Machine Regression to characterize
associations based on multi-pollutant exposures, and causal interaction-mediation decomposition analyses through ischemic
placental disease (preeclampsia, fetal growth disturbances). We will consider individual– and neighborhood–level con-
founders derived from residential census tracts. All associations will be corrected for simultaneous exposure and outcome
misclassification, as well as for exposure measurement error owing to maternal residential mobility through a regression
calibration approach. The ubiquitous nature of air pollution and weather exposures and their potential impact on adverse
perinatal outcomes, as well as the preliminary data supporting the associations, presents unprecedented opportunities to
address implications of the adverse impact of air pollution and weather-related exposures on placental abruption and
related obstetrical complications. This project aligns with 2 major critical areas of research–Co-exposures, and Data Sci-
ence and Big Data–outlined in the 2018-2023 strategic goals of NIH-National Institute of Environmental Health Sciences.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH SIGNIFICANCE) The overarching goal of this proposal is to examine the causal underpinnings between outdoor exposures to ambient air pollution and weather and placental abruption. The project will focus on delineating pathways to abruption, separating the impact of air pollution and weather that are implicated in acute and chronic placental abruptions. This project will provide unprecedented opportunities to address the implications of the adverse impact of air pollution and weather- related exposures on abruption and related obstetrical complications.